The role of depolarizing GABA in Alzheimer's disease

Summary
Alzheimer’s disease (AD) represents one of the most urgent unmet medical needs of our time. This devastating
condition has an enormous impact on the lives of patients, their families and society as a whole. Despite huge
research investments, the treatment options remain very few, their efficacy limited, and the occurrence of side
effects troubling. This is largely due to the fact that the cellular mechanisms of cognitive impairment in AD and
in other dementias remain unclear. The prefrontal cortex (PFC) is critical for higher brain function and goal-
oriented behavior. Numerous studies have identified a clear link between cortical electrical oscillations and
cognitive tasks, and aberrant oscillations have been observed in multiple cognitive disorders, including AD.
Because GABAergic inhibition is critical for oscillations, much attention has been given to the role of
excitatory-inhibitory (E/I) feedback in network dynamics, and altered E/I balance is suggested as critical in
many neurological disorders characterized by cognitive impairment. Despite the centrality of E/I imbalance in
numerous brain disorders, the underlying cellular mechanisms are mostly unknown. E/I imbalance may be
due to abnormalities in GABAergic (inhibitory) and/or glutamatergic (excitatory) signaling. Numerous studies
suggest that GABA signaling dysfunction underlies reduced brain oscillations and working memory deficits.
Accordingly, a recent meta-analysis has identified GABA signaling as particularly vulnerable and a potential
therapeutic target in AD. A peculiar biophysical feature of the GABAA current is that the value of its reversal
potential is close to the resting membrane potential of most neurons, and thus relatively small variations in the
current reversal potential may shift the current effect from hyperpolarizing to depolarizing. The value of the
GABAA current reversal potential is mainly regulated by the activity of NKCC1 (SLC12A2) and KCC2
(SLC12A5), two chloride-cation co-transporters that import and export chloride ions, respectively. Numerous
recent papers show that depolarizing GABAA current, which is the norm in early development, is present in the
adult PFC in diverse brain disorders and may underlie the altered E/I balance in these conditions. Here we
hypothesize that depolarizing GABAA current in the PFC of adult animals is a cause of E/I imbalance and
cognitive impairment in AD. Accordingly, our preliminary data suggest that restoration of GABAA inhibitory
function in the mPFC of an AD mouse model rescues cognitive performance. To test our hypothesis, we will use
perforated-patch recordings from acute slices to measure the GABAA current reversal potential, quantitative in-
situ hybridization to quantify the expression of NKCC1 and KCC2 RNA in the PFC of APP-Ki NLGF, 5xFAD and
control mice, and behavioral assays to determine the effect of pharmacological inhibition of cortical NKCC1 on
working and recollection memory in AD mice. Besides the advancement in understanding basic biological
mechanisms of cognitive impairment, our experiments may have immediate translational potential, as there
are FDA-approved NKCC1 blockers that could rapidly be tested in clinical trials.

Public health relevance
Narrative The mechanisms of cognitive impairment in Alzheimer’s disease are often unclear, as there is often a lack of a clear correlation between pathological findings and clinical symptoms. We hypothesize that the appearance of depolarizing GABA current in the cortex of animal models of Alzheimer’s disease has a causal role in cognitive impairment and that normalization of GABAA current function rescue cognition in these animals.